DEVELOPMENTAL RESEARCH PROGRAM

There are four developmental projects, each budgeted for $60,000 in the first year and funded for three years. The intent of this program is to provide adequate funding for established investigators to make substantial contributions to breast cancer. Programmatically, these projects are all concerned with the development and preclinical testing of novel therapeutic strategies. Therefore, each of these projects is approached in this application as small RO-1 type grants, similar in form to the major projects presented earlier. As emphasized in the introduction, and discussed in the section describing our Administrative Core, a P2O Planning Grant funds smaller scale pilot projects.